Improving Neonatal health Through Rapid malaria testing in Early Pregnancy with high-sensitivity Diagnostics (INTREPiD)

Project Summary/Abstract
Newborn health has improved globally but there remains a critical need in resource-limited settings to reduce
neonatal mortality. Nearly all infant deaths in sub-Saharan Africa occur in babies that are small or low
birthweight, which often result from antenatal infections with Plasmodium falciparum. These malaria effects can
be partially mitigated by pregnancy-specific measures including the administration of monthly antenatal doses
of sulfadoxine-pyrimethamine as intermittent preventive therapy during pregnancy (IPTp-SP), but these are not
typically implemented until the 2nd trimester, and so do not mitigate the risks of infection in the 1st trimester. It
is now feasible to include 1st trimester screening for malaria parasites owing to: i) updated WHO guidelines that
recommend an expended schedule of 8 ANC contacts, with the first prior to 12 weeks gestation, ii) the
availability of high-sensitivity malaria rapid diagnostic tests (HS-RDT) with enhanced detection of low-density
infections, and iii) accumulated safety data that enable the use of Artemether-Lumefantrine (AL) for malaria
treatment in the 1st trimester. We hypothesize that, compared to women who enter ANC and receive usual
care, women who are screened in the 1st trimester with an HS-RDT will have a lower prevalence of a poor
pregnancy outcome, and we will test this through the Improving Neonatal health Through Rapid malaria testing
in Early Pregnancy with high-sensitivity Diagnostics (INTREPiD) study in Western Kenya and the Democratic
Republic of the Congo (DRC). In Aim 1, the INTREPiD study will enroll women in the 1st trimester and
randomize them 1:1 to usual care or to screening with an HS-RDT followed by treatment of positives with AL,
and then follow them through delivery. Following the 1st trimester intervention, all women will receive usual
ANC, including IPTp-SP. The primary outcome will be the composite outcome of low birthweight, small-for-
gestational age, preterm birth, fetal loss, or neonatal death. In Aim 2, we will measure the therapeutic efficacy
and pharmacokinetics of AL administration in the 1st trimester through a population PK study following standard
AL dosing and compare PK parameters with historical controls. In Aim 3, we will use trial data to model the
potential incremental benefits of enhanced-sensitivity diagnostics and alternate treatment regimens on the risk
of an adverse pregnancy outcome in order to maximize the impact of our trial data. Collectively these data will
guide the development and implementation of fresh approaches to intercept parasites early in pregnancy and
thereby enhance pregnancy outcomes and newborn health.

Public health relevance
Project Narrative There exists a critical need in resource-limited settings to identify new strategies to reduce newborn deaths, many of which result from antenatal malaria infections with Plasmodium falciparum. We hypothesize that a strategy of screening pregnant women in malaria-endemic areas in the first trimester with a high-sensitivity rapid diagnostic test for parasites followed by treatment if positive with Artemether-Lumefantrine will reduce the risk of a negative pregnancy outcome. We will test this hypothesis in a clinical trial in Western Kenya and the Democratic Republic of the Congo, as well as study the pharmacokinetics of these antimalarials in the 1st trimester and estimate the incremental benefits of alternate approaches, in order to collectively identify a new strategy to improve pregnancy outcomes and newborn health in malaria-endemic areas.